Immune Tolerance Network

Project Summary/Abstract: Anti CD14 (CaTT)
The SARS-CoV-2 pandemic continues to spread around the world, causing widespread illness
with significant mortality, overburdening health care systems and disrupting the global
economy. Severe illness is caused by viral infection of host cells leading to the generation of
secondary inflammatory responses that cause serious organ injury. We propose to test a novel
treatment that will add to antiviral therapy by blunting the host innate immune inflammatory
response to virally infected host cells using IC14, a specific blocking monoclonal antibody to the
CD14 pattern recognition receptor on macrophages, dendritic cells and other cells of the innate
immune system. In combination with a primary antiviral drug (e.g. remdesivir), this treatment
strategy should reduce host inflammatory responses and speed resolution of illness. The
primary hypothesis is that inhibiting the CD14 pattern recognition receptor will reduce the
intensity of deleterious host inflammatory responses to the SARS-CoV-2 virus and secondary
tissue damage and improve outcomes in patients with COVID-19 illness. We will conduct a
multicenter randomized controlled trial in 300 patients in 15 US clinical centers in order to
determine the efficacy and safety of IC14 in patients hospitalized with respiratory disease due
to SARS-CoV-2. In Aim 1 we will determine whether IC14 improves the time to resolution of
disease using an eight-point ordinal scale. In Aim 2 we will determine whether IC14 reduces
the need for high level respiratory support, including ICU care. In Aim 3 we will determine
whether IC14 reduces the severity of systemic inflammation and the recovery of virus in nasal
swabs. Overall, this program will determine whether treatment with IC14 is an effective new
approach to lessen systemic inflammation and organ injury triggered by the SARS-CoV-2 virus
and improves outcomes in patients hospitalized with COVID-19 illness.

Public health relevance
Project Narrative: Anti CD14 (CaTT) New strategies for addressing the COVID-19 pandemic are urgently needed, including vaccines, antiviral agents and treatments to modify host inflammatory responses that cause respiratory, cardiac, renal and other organ failures and death. We will conduct a multicenter randomized trial to test the beneficial effects of a new antibody treatment that blocks a very early step in production of host inflammatory response to the SARS-Co-V2 virus. This approach should inhibit many downstream events that initiate and perpetuate inflammation and thereby reduce serious organ injury. If successful, this new treatment will shorten hospital stay, reduce the need for intensive care and improve outcomes in patients with COVID-19 illness.